Exposure to volatile organic compounds and glycemic dysregulation among oil spill cleanup workers

Project Abstract
Diabetes, the clinical manifestation of glycemic dysregulation, leads to devastating complications as well as
high medical costs for both the individual and society. Diabetes is increasing in prevalence and is
disproportionately high among certain minority populations, and particularly among those of low socioeconomic
status within those populations. Limited evidence suggests a role of environmental factors in the etiology of
glycemic dysregulation and highlights the need for further research to better understand these relationships.
Exposure to the BTEX-H (benzene, toluene, ethylbenzene, xylenes, and hexane) mixture is ubiquitous and is
associated with glycemic dysregulation in epidemiologic and toxicological studies, but there are clear gaps in
the literature. One gap is in the assessment and analysis of exposures; previous work primarily addresses the
BTEX-H chemicals singly, and not all of the BTEX-H chemicals have been investigated as such. In contrast the
BTEX-H chemicals are often experienced jointly and must be analyzed accordingly. Additionally, previous work
has not incorporated individuals with large magnitude and varied exposures, making it difficult to isolate
exposure effects. The proposed research will address these gaps by analyzing these associations in a well-
characterized, prospective cohort of oil-spill workers with a wide range of exposures using mixtures analysis
methods. The goals of this proposal are a) to examine real-world exposure effects of BTEX-H mixtures on
incident diabetes up to 10 years post-exposure among a cohort of oil spill workers, b) to determine racial/ethnic
and socioeconomic category specific exposure burden, outcome burden, and BTEX-H mixture to clinical
diabetes associations, and c) to examine the effect of BTEX-H mixture exposure on glycemic dysregulation by
relating the mixture to i) glycosylated hemoglobin levels and ii) change in glycosylated hemoglobin levels
between two time points up to 5 years apart.
My training plan will allow me to further develop the skills necessary to complete the proposed research and to
pursue a successful career as an independent researcher. These skills are a) to become fluent in exposure
mixtures theory and analysis methods; b) to develop skills in operationalizing socioeconomic and racial
disparities processes in quantitative research; c) to further develop skills necessary for a strong scientific
career by refining my written communication, expanding my professional network for collaboration, and further
evolving my presentation strategies; and d) to obtain additional training in the responsible conduct of research,
especially in the context of disaster and environmental epidemiology research. This training will propel me
toward my goal of studying long-term health outcomes at the intersection of disasters, environmental
exposures, and social disparities processes.

Public health relevance
Project Narrative Diabetes, the clinical manifestation of glycemic dysregulation, is a devastating and increasingly prevalent condition that disproportionately affects certain racial and ethnic groups and those of low socioeconomic status. To date, the limited epidemiologic evidence suggests an association between the BTEX-H chemicals (benzene, toluene, ethylbenzene, xylene, and hexanes), which are ubiquitous, and glycemic dysregulation. The proposed study will examine glycemic dysregulation in relation to joint exposures to the BTEX-H chemicals, with a particular focus on potential racial/ethnic and socioeconomic disparities.